Effects of Functional Food Diets on Cardiometabolic and Metabolomics Profiles in Minority Youth

PROJECT SUMMARY / ABSTRACT
This proposal outlines a career development plan to help Dr. Jaapna Dhillon complete her postdoctoral training
and establish an independent research program focused on personalized dietary interventions to reduce
cardiometabolic risk in minority populations. Her training will be conducted in a multidisciplinary group of
scientists with research expertise in nutrition science, health disparities, molecular cell biology, metabolomics
and computational biology. Her advisory team will provide an outstanding training environment that will allow
her to fill critical gaps in her toolkit needed to use an integrative and personalized approach to nutrition. This
award will enhance her knowledge in developing culturally sensitive nutrition interventions and cardiovascular
physiology, and provide advanced training in metabolomics and computational biology. During the training
phase of this award, she will strengthen her scholarly activities, establish important collaborations, and acquire
critical data that will ensure her successful transition to independence. Rational: The incidence of diet-related
cardiometabolic disorders is increasing at an alarming rate in racial/ethnic minority groups such as Asians and
Hispanics, and are much higher than Non-Hispanic Whites in the United States. [8]. However, whether
improvements in diet quality will influence minority groups at high risk of cardiometabolic diseases differentially
than Whites at high risk is not well understood. Functional foods such as nuts, whole grains and vegetables
can help ameliorate cardiovascular disease and reduce the risk of type 2 diabetes. However, most studies on
functional foods and health have been overwhelmingly performed in middle-aged to older non-Hispanic White
adults, with young minority populations being greatly neglected. Adapting a functional food diet at earlier life
stages may prevent or ameliorate metabolic disorders later in life in minority populations that are at greater risk
for developing chronic metabolic diseases. Our central hypothesis is that adapting a personalized functional
food diet at earlier life stages will have greater beneficial effects on carbohydrate and lipid regulation pathways
in minority youth at risk for developing cardiometabolic disorders compared to White youth at risk. Design: The
mentored phase study will 1) examine the effects of almonds on blood glucose regulation pathways using
metabolomics techniques and 2) provide preliminary data for the development and testing of a model that can
predict effects of almonds on metabolic consequences in minority youth. The independent phase study will
evaluate the long term effects of a personalized diet rich in functional foods on pathways of carbohydrate and
lipid regulation in relation to the gut microbiome and cardiovascular outcomes in minority youth at high risk for
cardiometabolic disorders. Relevance: The proposed studies will provide an initial evidence base for the
health benefits of personalized functional food interventions in minority youth. This innovative dietary strategy
may be more effective at reducing risk and ameliorating diet-related cardiometabolic disorders than
conventional dietary advice in this population.

Public health relevance
PROJECT NARRATIVE The proposed research will provide an initial evidence base for the health benefits of personalized functional food interventions in minority youth. This innovative dietary strategy may be more effective at reducing risk and ameliorating diet-related cardiometabolic disorders than conventional dietary advice in this population.